Hydrogel Delivery of Bacteriophage to Treat Wound Infections

Abstract Summary
Bacteriophages—viruses that kill bacteria—are a powerful weapon against anti-microbial resistant (AMR)
pathogens, including skin, bladder, and ear infections caused by the bacterium Pseudomonas aeruginosa (Pa).
Phages require sustained exposure to kill bacteria effectively but unfortunately are rapidly cleared from
circulation, making intravenous delivery impractical. We need better ways to deliver topical phage therapy.
The overall goal of this work is to develop a translatable hydrogel platform technology for delivering topical
phage therapy in a local and sustained manner. The concept is to use dynamic covalent crosslinks to weakly
connect hydrogel polymers to peptides naturally presented on the phage capsid, thereby allowing the phage to
slowly diffuse out of the gel. This approach does not require any modification of the phages. In our preliminary
studies, we have developed hydrogels that exhibit sustained release of high dose phage as well as delivery of
multiple phage types. Delivery via dynamic covalently crosslinked hydrogels represents an innovative,
groundbreaking approach to phage therapy with applications across many tissue sites and infections.
To facilitate these studies, we have developed a novel pre-clinical model of phage therapy. This model
incorporates immunologically intact animals, bacterial isolates from human wound infection cases, and biofilm
infections to recapitulate chronic wounds. In preliminary studies, we find that repeated but not one-time treatment
eradicates infections in this model, indicating a requirement for sustained phage delivery.
We have also developed innovative radionuclide imaging techniques to facilitate the assessment of phage
pharmacokinetics and biodistribution within the body. In these studies, we have administered phages
radiolabeled with technetium-99m (99mTc), a widely used SPECT imaging radio-isotope, in conjunction with
scintillation well counting of 99mTc activity in cells and tissues. In this way, imaging can inform phage delivery
without adversely impacting phage infectivity. 5-EdU-labeled phages will allow us to assess phage delivery and
replication in bacteria in pharmacodynamic studies.
Our hypothesis is that hydrogels can deliver local, sustained bacteriophage and eradicate bacterial
infections. To test this, first we will identify the dosing and delivery requirements for effective topical phage
therapy. Next, we will develop imaging technologies to assess the pharmacokinetics of phage delivery. Finally,
we will engineer hydrogels for effective topical delivery of phages to wounds and other tissues.
Together, these foundational studies will revolutionize phage therapy by enabling effective, sustained local
delivery of phages. Our vision is that this hydrogel phage delivery platform can be adapted broadly for use with
diverse phages, microbial pathogens, and in multiple tissue contexts, including skin, bladder, and ear infections.

Public health relevance
Project Narrative Bacteriophages, viruses that kill bacteria, are a promising but currently inadequate solution to the problem of multidrug-resistant bacterial infections. We propose to develop hydrogel-based wound dressings to enable consistent, effective delivery of phage therapy and imaging platforms to assess this delivery. These studies have the potential to transform the treatment of chronic, multidrug-resistant bacterial infections.